Dispersion and the Biofilm Matrix of Pseudomonas aeruginosa

PROJECT SUMMARY
Antimicrobial resistant, chronic infections are one of the greatest challenges facing our society today. This
problem is so significant that the World Health Organization named antibiotic resistance as one of the top ten
threats to global health in 2019. More than 80% of these infections have been attributed to the remarkable
capabilities of bacteria to form biofilms, communities of microorganisms encased in a protective matrix of
extracellular polymeric substance, that are irresponsive to antimicrobials. Pseudomonas aeruginosa is the 2nd
leading cause of these infections, and routinely the most common cause of fatalities in patients with nosocomial
infections. Dispersion is considered a promising avenue open for biofilm control, by assisting in resolving biofilm-
associated infections. This is because dispersion is an active, regulated process by which bacteria escape
biofilms as free-living cells that are once again susceptible to antimicrobials, with dispersion thus capable of
enhancing the efficacy of antibiotics. However, while dispersion cue sensing by P. aeruginosa and how these
cues are translated into the modulation of the c-di-GMP pool has been elucidated in great detail, little is known
about downstream events enabling P. aeruginosa to egress from the biofilm, the contribution of c-di-GMP, or
factors driving the virulence switch by dispersed cells. Using RNA-seq, we have identified genes that are unique
to dispersed cells (termed “dispersion regulon”) and contribute to the phenotype ascribed to dispersed cells
including drug susceptibility, virulence, and matrix degradation. We confirmed factors involved in matrix
degradation and the reinforcement of the biofilm matrix to contribute to dispersion. However, no obvious matrix
degrading enzymes have been thus far identified which target the matrix EPS Psl, suggesting differences in
matrix degradation and dispersion by different classes of matrix-producing P. aeruginosa strains. Moreover, our
findings suggest that the modulation of c-di-GMP is not sufficient to induce dispersion and only explains some
of the phenotypes of dispersed cells. Based on these premises, we hypothesize that dispersion and dispersion-
related phenotypes require c-di-GMP-(in)dependent pathways including genes and gene functions involved in
matrix degradation that likely differ amongst the classes of matrix utilization. The goal of this project is to
elucidate the signaling and regulatory events leading to dispersion including matrix-degradation, and dispersed
cells adopting an acute virulence phenotype. We will therefore elucidate in Aim 1 pathways leading to dispersion
and dispersion-related phenotypes in vitro and in vivo, and spatio-temporally assess the fate of matrix
components during dispersion in Aim 2. Aim 3 aims at determining whether the dispersion and factors required
for dispersion are similar or are different in non-mucoid clinical isolates representing 4 different matrix classes.
We anticipate our findings to not only contribute to understanding infection but also assist in guiding the
development of dispersion towards an adjunctive therapy for biofilm control.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa is the cause of many serious human infections, particularly in hospitalized patients with weak immune systems and burn wounds, due to the ability of this human pathogen to form biofilms that are highly resilient to antimicrobial treatment. This proposed research is aimed at elucidating genes and gene functions that enable dispersing bacteria to liberate themselves from the biofilm matrix, regardless of the biofilm matrix composition, and drive the phenotype of dispersed cells. Findings from the proposed study are anticipated to lead to the identification of factors and mechanisms contributing to biofilm dispersion.